Kansas Animal Food Regulatory Program Standards Maintenance

Project Summary/Abstract
The Kansas Department of Agriculture Dairy and Feed Safety Program (KDADFS) aims to help
create a national, fully integrated food safety system by maintaining full conformance with the
Animal Food Regulatory Program Standards (AFRPS). The program standards establish a
uniform foundation for the design and management of state regulatory programs. Through self-
assessment, planning, training, auditing, compliance, and outreach, KDADFS will improve and
enhance its risk-based animal food safety program.
The Kansas Department of Agriculture Laboratory (KDAL) serves as the primary testing
laboratory for KDADFS and plays an integral part in maintaining the Laboratory Service Standard
found in the AFRPS. KDAL will produce data of sufficient quality to be defensible when used in
enforcement situations. Under the current version of ISO/IEC 17025, KDAL will provide a
comprehensive system to ensure quality analytical results. The accreditation attests the
competency and technical capabilities of a laboratory's ability to perform tasks and supports the
traceability of data generated. The data is defensible to an internationally recognized standard
that is independent of laboratory personnel or influences. State animal food laboratory
accreditation to the current version of ISO/IEC 17025 will play a vital role in achieving the goal of
having an integrated food safety system.

Public health relevance
Project Narrative By participating in this cooperative agreement, the Kansas Department of Agriculture's Dairy and Feed Safety Program (KDADFS) will successfully maintain and enhance the Animal Food Regulatory Standards (AFRPS) set forth by the Food and Drug Administration (FDA). KDADFS will further improve its risk-based animal food safety program and ensure a safer animal food supply without adversely impacting the manufacturers of animal food within the state of Kansas. Participation will further enable KDADFS in building a mutual state and federal collaboration.